The Impact of Cannabis Use Disorder and its Treatment on Opioid-related Health Consequences: A Longitudinal Study of VA Patients

PROJECT SUMMARY/ABSTRACT
Over 600,000 people have died from opioid-related overdoses in the United States (U.S.) since 1999, and rates
of opioid-related hospitalizations, overdose, and opioid use disorder (OUD) remain high despite policy reforms
aimed at reducing their public health burden. Alongside the ongoing opioid crisis, cannabis use has increased
significantly, with 40 million adults using cannabis in 2022, 33% of whom will develop cannabis use disorder
(CUD). Despite the negative health consequences of CUD, access to its treatment (i.e., non-pharmacologic
interventions) remains limited. The ongoing opioid crisis coupled with a dramatic increase in cannabis use in
recent decades has prompted research into whether cannabis use contributes to or mitigates opioid-related
health risks. Although cannabis use may influence opioid use through various mechanisms, research examining
the impact of CUD on opioid-related outcomes remains limited. No longitudinal studies have examined
associations between CUD and OUD, opioid-related hospitalizations, and fatal or non-fatal overdoses, and
whether receipt of CUD treatment reduces these risks. CUD substantially impacts patients who receive care in
the Veterans Health Administration (VHA), one of the largest healthcare systems in the U.S. In the VHA, CUD
prevalence has nearly quadrupled since 2005, and opioid-related hospitalizations and overdoses have
increased. Our preliminary 2005-2022 data from ∼4.5 million VHA patients show increases in co-occurring CUD
and OUD with an adjusted past-year prevalence of OUD that is markedly higher in patients with CUD (11.36%-
13.19%) than those without (0.72%-1.08%). From 2005-2020, the adjusted annual opioid-related mortality rate
per 100,000 persons was also substantially higher in patients with CUD (42.0-180.53) than without CUD (18.9-
33.2 deaths), with a between-group disparity that widened over time. Given these initial results and growing
concerns about the health risks of CUD, we propose a cohort study that leverages the size and scope of the
VHA electronic health record (EHR) to 1) examine CUD as a risk factor of subsequent opioid-related health
outcomes; 2) identify potential barriers and facilitators of non-pharmacologic interventions among patients with
CUD and whether receipt of CUD treatment is associated with reduced risk of subsequent opioid-related
outcomes, and 3) determine individual and state-level modifiers of these associations. These research aims are
complemented by an outstanding interdisciplinary research team with extensive prior collaborations yielding
high-impact research, and expertise in veteran health, SUDs and health services. By identifying CUD as a
potential risk factor of opioid-related harms and establishing if engagement in CUD treatment may mitigate these
risks, this research has important clinical and public health implications for the ongoing opioid crisis in the U.S.
and will provide necessary information to clinicians, healthcare administrators, and policymakers on the opioid-
related public health consequences of CUD and its treatment.

Public health relevance
PROJECT NARRATIVE Cannabis use and cannabis use disorder (CUD), potential risk factors for opioid-related health risks, are dramatically rising amidst the ongoing U.S. opioid crisis. Still, access to CUD treatment remains limited. CUD substantially impacts military veterans receiving care in the Veterans Health Administration (VHA), a large healthcare system with established referral pathways and expanded access to CUD treatments. Using VHA electronic health record data, we will examine longitudinal differences in opioid-related health outcomes associated with CUD and CUD treatment interventions to identify factors perpetuating the U.S. opioid crisis.